Fn14, non-canonical NF-kappaB and downstream signaling in neuropathic pain

BACKGROUND: The ongoing opioid epidemic is driven in part by legitimate use of opioids prescribed for
neuropathic pain. Targeting alternative pathways for pain control using non-addicting drugs is a major goal of
neuropathic pain research. After peripheral nerve injury (PNI), cytokines and chemokines are upregulated
centrally, where they contribute mechanistically to the pathogenesis of neuropathic pain. Reactive astrocytes in
the dorsal horn exhibit a chronically activated, pro-inflammatory secretory (CAPS) phenotype characterized by
secretion of numerous factors, including interleukin-6 (IL-6), chemokine C-C motif ligand 2 (CCL2), chemokine
C-X-C motif ligand 1 (CXCL1) and nerve growth factor (NGF). The post-PNI astrocytic CAPS phenotype
contributes to both inflammation and neuronal hyperactivation via neuronal chemokine receptors, leading to
neuropathic pain. Canonical NF-κB signaling is known to play a crucial role, but surprisingly, despite its
documented importance in numerous inflammatory conditions involving most organs including the brain, non-
canonical NF-κB signaling via the p52:RelB heterodimer has not been identified previously in PNI. New work
from our laboratory demonstrates the novel finding that non-canonical NF-κB signaling by the tumor necrosis
factor-like weak inducer of apoptosis (TWEAK) / fibroblast growth factor-inducible 14 (Fn14) axis is prominent
after PNI, especially in dorsal horn astrocytes, and may be responsible for transcriptional expression of Sur1-
Trpm4 in these cells. Moreover, our preliminary data suggest that glial Sur1-Trpm4 plays a crucial role in
regulating the expression of IL-6, CCL2 and CXCL1. Our central hypothesis is that, in dorsal horn astrocytes
post-PNI, TWEAK-induced non-canonical NF-κB signaling is an upstream regulator of Sur1-Trpm4 expression,
and that Sur1-Trpm4, in turn, regulates the expression of the downstream effectors, IL-6, CCL2 and CXCL1,
which promote chronic neuroinflammation, neuronal hyperactivation and neuropathic pain.
DESCRIPTION: This project has three mechanistic aims. In Aim 1, genetic (Tweak–/–, Fn14–/–, p100–/–,
Abcc8–/–, either global or GFAP-specific or GFAP-&-site-specific) and pharmacological (anti-TWEAK antibody,
glibenclamide) experiments will be carried out to determine the role of non-canonical NF-κB and Sur1 in
GFAP-expressing glia in sciatic n. vs. dorsal horn in two neuropathic pain models: sciatic n. cuffing and sciatic
n. exposure to HIV/gp120 protein. In Aim 2, we will expand upon in vivo and in vitro data from chromatin
immunoprecipitation to establish the role of non-canonical NF-κB in the expression of functional Sur1-Trpm4
channels. In Aim 3, we will corroborate and expand upon in vivo and in vitro data to establish the role of Sur1-
Trpm4 in regulating Ca2+/calcineurin-dependent transcription of IL-6, CCL2 and CXCL1. This project is the first
to study non-canonical NF-κB in dorsal horn vs. sciatic n. glia in neuropathic pain, and will help identify novel
druggable targets to ameliorate neuropathic pain using non-addictive drugs.

Public health relevance
PUBLIC HEALTH RELEVANCE: Nearly 530 people die each week in the USA due to opioid overdose, demanding urgent solutions for this public health crisis. In many cases, previously opioid-naive patients are prescribed opioids for neuropathic pain caused by one of numerous etiologies. Evidence-based recommendations for treating neuropathic pain include opioids, which remain the most consistently effective class of drugs for this condition. However, in light of the opioid epidemic, recent Centers for Disease Control and Prevention guidelines advise against the routine use of µ-opioid receptor-selective agents. Targeting non-opioid pathways involved in the central mechanisms required to establish and sustain neuropathic pain has the potential to dramatically impact this epidemic of opioid addiction and overdose.